Promoting adult hippocampal neurogenesis in Alzheimer's Disease using an antibody-based therapy

PROJECT SUMMARY
Alzheimer's disease (AD) is a looming public health crisis that threatens millions of patients' ability to
experience healthy aging. In addition to the challenges that AD poses to patients, healthcare providers and
caregivers, there is also tremendous economic burden associated with AD and related dementias – estimated
to be well over $200B/year in the United States alone. Hundreds of attempts to develop therapies to halt the
progression of or reverse AD have been tried, but unfortunately none have been successful to date. The
results of these studies strongly support the pursuit of new therapeutic modalities and molecular targets. Adult
hippocampal neurogenesis (AHN) has long been appreciated as critical for normal learning and memory in
rodents, however its role in humans has historically been less clear. Several preclinical studies have
underscored the role of AHN in improving cognition in an AD environment. Critically, several recent studies
have supported that AHN is also robust in humans and persists throughout life in healthy adults, but declines
dramatically in AD patients. Thus, restoring AHN has emerged as an attractive target for early intervention,
ameliorating or delaying the onset of AD symptoms.
In the proposed experiments, Bolden Therapeutics will develop therapeutic monoclonal antibodies (mAbs) that
reduce bone morphogenetic protein (BMP) signaling in neural stem cells in vivo to increase AHN via targeting
a novel BMP co-receptor. BMP signaling is an important negative regulator of adult neurogenesis, and
increases both in normal aging and in AD. Inhibiting BMP signaling has been shown to increase neurogenesis,
and that is the expected outcome of our project. The mAbs will be generated by immunizing proprietary, knock-
in mice, which are expected to have a more robust immunological response and will overcome tolerance. The
most promising mAb candidate will be administered using both direct hippocampal stereotactic injection and
systemic delivery in AD mice to provide proof of concept data for augmenting AHN in the setting of disease
pathology. These studies will support future Phase II studies for further characterization of the mAb, including
evaluating its effect on not only neurogenesis, but also cognition and additional pathological hallmarks (e.g.,
amyloid, tau, inflammation). Ultimately, our goal is that these studies will enable Bolden to generate the
requisite data package to begin clinical development of a pro-neurogenic therapeutic antibody for improving
the clinical course in MCI/AD, as well as potentially in other neurological indications.

Public health relevance
PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE: Augmenting neurogenesis in the setting of neurological disease pathology is a highly promising yet understudied approach. The experiments proposed herein will generate lead compounds and provide crucial in vivo data from an Alzheimer's disease mouse model that will guide future studies. If successful, the experiments performed in this Phase I effort will provide in vivo proof of concept data to support an entirely novel therapeutic modality to combat Alzheimer's disease via increasing adult hippocampal neurogenesis.